"TECHNICAL CORE"

We are requesting support for a Technical Core Unit to integrate the scientific activities of the Program Project, thus relating directly to the communal needs of the three individual projects. These needs include program centralized technical services (muscle histochemistry, biochemistry, and molecular genetic laboratories; tissue culture and cybrid generation), service contracts and supplies for common equipment (e.g liquid nitrogen).

Public health relevance
The function of the Technical Core is to provide technical support to all three subprojects that are moreeasily provided by a centralized source that avoids duplication of time, resources, effort, and money.